CDC Community Guide Office Support for Health Equity and Ending the HIV Epidemic in the U.S. (EHE) Initiatives

Project Objective – What is the goal or the objective (or desired outcomes) of this project?
Completion and dissemination of Community Guide systematic reviews of the effectiveness of
community-based health promotion and disease prevention programs, services, and policies related
to EHE, health disparities, mental health, and substance use.

Duties of each party – What is each party responsible for?
This IAA will support the work related to Community Guide systematic effectiveness reviews, which
will be conducted under the oversight of senior Community Guide scientists, with the collaboration
of NIH subject matter experts and scientists from CDC.
The NIH holds official liaison status with the CPSTF. The ODP serves as the organizational hub for the
liaison relationship, with both the primary (Elizabeth Neilson) and alternate (Bob McNellis) liaison
representatives coming from ODP. The ODP liaison representatives coordinate all NIH relationships
with the CPSTF and CGO.
The CGO often embeds NIH scientific representation on its systematic review Coordination Teams.
For example—two NIH scientists (Michael Stirrat and Greg Greenwood) from the National Institute
on Mental Health, who are engaged in HIV research, are members of the Community Guide HIV
Coordination Team. The CGO will also seek subject matter experts from NIH to serve on Coordination
Teams related to health disparities, mental health, and substance use. The Coordination Teams
provide subject matter expertise and guidance for all work on systematic reviews. For dissemination
of systematic review findings and CPSTF recommendations, the CGO organizes meetings with CPSTF
liaisons, CDC program staff, and members of the Coordination Team to discuss plans for maximizing
outreach efforts via partners’ available communication channels. NIH liaisons have been part of
Community Guide dissemination efforts and can help further spread findings to applicable
stakeholders.
NIH support for this IAA will be provided by ODP and the Office of AIDS Research (OAR). NIH funding
will support SGO staff in conducting systematic reviews and coordinating with CPSTF members, other
CDC offices, and partner organizations to disseminate the review findings, evidence gaps, and
implications for practice. The reach of the scientific and promotional materials on The Community
Guide website will be evaluated by monitoring website metrics monthly. NIH funds will be used to
support a health communication specialist to write, edit, and format translation and promotional
products. The funding will support exploratory and scoping research to identify potential intervention
approaches for future Community Guide systematic reviews.
The CGO will contribute the following: a Coordinating Scientist to oversee work related to systematic
reviews (including exploratory research); systematic review software; technical assistance from CGO
senior scientific leadership; all logistical support; all resources required for holding CPSTF Meetings
where review findings may be presented to the CPSTF; and resources required for dissemination.
Other CDC offices (e.g., Division of HIV Prevention) will contribute staff to assist with systematic
reviews, provide subject matter expertise, and support dissemination of the review findings and
CPSTF recommendation to stakeholders.